Training in Pediatric Nonmalignant Hematology and Stem Cell Biology

Project Summary/Abstract
Very little is understood about the molecular pathogenesis of many hematologic diseases in children.
We have developed an innovative, multidisciplinary training program in pediatric nonmalignant
hematology and stem cell biology with investigators who have unique expertise and can foster
multidisciplinary research. Currently, there is no other program at Stanford University that supports the
training of MD, MD/PhD, or PhD fellows to study Pediatric Nonmalignant Hematology and Stem Cell Biology.
Given the declining number of translational and basic scientists in this area of research, our training program is
critical to continue advancements in the field and maintain a pipeline of researchers focusing on pediatric
nonmalignant hematology and stem cell biology.
We propose a training program that integrates a variety of disciplines and expertise, including molecular
and cellular hematopoiesis, alternative organism models, stem cell transplantation, proteomics/genomics,
translational research, and bioinformatics. In this revised renewal application, we have added new faculty
with expertise in novel, cutting edge technologies; new aspects of the program in translational
research in collaboration with experts in Silicon Valley including those in pharmaceutical and
biotechnology industries; an expert in bioinformatics and a new bioinformatic course for trainees, and
new junior faculty who will be mentored to become T32 faculty mentors in the future.
In this application, we seek funding for two MD, MD/PhD, or PhD postdoctoral fellows per year for a
maximum of two years. Trainees will have the opportunity to develop research in one of the 22 established
faculty mentor’s laboratories. Trainees will be selected from a pool of approximately 54 eligible internal
postdoctoral fellow candidates in addition to external candidates based on their academic potential, career
goals, and research achievements. The second year of funding will depend on their progress reports.
Trainees will participate in journal clubs, hematology and stem cell biology lectures, clinic conferences, and
research seminars. Career development workshops for trainees include Grant Writing, Professionalism, and
Leadership. Trainees will also be required to take a course on Pediatric Nonmalignant Hematology and Stem
Cell Biology and Ethics and Scientific Integrity. Trainees will meet with the Program Directors and Scholarship
Oversight Committees every 6 months to monitor progress and will present their work at national and
international meetings. The External Advisory Committee will review the program and meet with trainees
every year. We will utilize the strengths of Stanford University to develop research collaborations in Pediatric
Nonmalignant Hematology and Stem Cell Biology, including the breadth and depth of investigators across
many disciplines, to train future leaders in the field.

Public health relevance
Project Narrative The goal of the Training in Pediatric Nonmalignant Hematology and Stem Cell Biology Program is to train MD, MD/PhD, and PhD postdoctoral fellows to perform innovative basic, translational, and clinically relevant research. There is a gap in training in Pediatric Nonmalignant Hematology and Stem Cell Biology at Stanford. Training future leaders and researchers in the field of Pediatric Nonmalignant Hematology and Stem Cell Biology will advance our knowledge of Pediatric Hematologic and Stem Cell diseases; this will result in improved treatment and overall quality of life in children with nonmalignant hematologic and stem cell diseases.